Weight Loss and Maintenance for Individuals with IDD

DESCRIPTION (provided by applicant): Individuals with IDD have obesity rates that exceed those in the general population, consume energy dense diets, and perform very little physical activity (PA). Overweight and obesity are independent risk factors for chronic disease such as cancer, diabetes, hypertension, and cardiovascular disease in both the general population and those with IDD. However to date, limited research on weight management for individuals with IDD has been completed. We have recently initiated a 6 month pilot investigation on weight loss in 73 individuals with IDD and 66 completed the 6 months. We modified the Stop Light Diet (SLDm) to include reduced energy pre-packaged meals (PM) to reduce energy and fat content, and encouraged consumption of low energy shakes and 35 fruits and vegetables (F/V) per week. SLDm resulted in an average 6.1 percent reduction in weight at 6 months and increased F/V consumption. We continue to follow the 66 participants for an additional 6 months and weight loss at 9 and 12 months is 8.2 percent and 9.1 percent from baseline. Although our pilot results are encouraging, this study was conducted in a small sample with no comparison group, and funding only allowed for measurement of weight during follow up. Therefore, we propose to conduct an adequately powered randomized trial to evaluate weight loss and weight maintenance. Social Cognitive Theory (SCT) guides the interventions using both sides of the energy balance equation (i.e. energy intake and energy expenditure) in overweight and obese individuals with IDD. We will compare participants who use the SLDm with participants who use a recommended care diet (RC). Following a 6 month period of reduced energy intake (weight loss), both groups will be placed on a diet with sufficient energy to maintain weight (i.e. weight maintenance) for and additional 12 months. Both groups will participate in a PA program that has been shown to improve metabolic risk factors such as blood pressure, triglycerides, and cardiovascular fitness, and has provided modest weight loss in gymnasium and laboratory settings. In the current proposal the PA program will be modified for home use and conducted for the entire 18 month trial. We expect the SLDm group to have greater weight loss at 6 months and less weight regain from 6 to 18 months compared to RC. We have proposed mediation analysis for components of SCT for both participant and care givers to discover what components of the intervention affected weight change. We will conduct extensive process evaluation will collect quantitative and qualitative data to assess how well the programs were implemented and accepted by participants.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narrative. There are few efficacious treatment options for individuals with IDD who wish to lose weight and reduce health risk. Both SLDm and RC diets combined with PA may provide weight loss and reduction of health risk, although we expect greater and clinically meaningful weight loss and maintenance with SLDm compared to RC. Translation of the 2 approaches to weight loss can be accomplished through the existing IDD agencies and care providers with modest training. Narrative. There are few efficacious treatment options for individuals with IDD who wish to lose weight and reduce health risk. Both SLDm and RC diets combined with PA may provide weight loss and reduction of health risk, although we expect greater and clinically meaningful weight loss and maintenance with SLDm compared to RC. Translation of the 2 approaches to weight loss can be accomplished through the existing IDD agencies and care providers with modest training. __SpecificAimsTextDelimiter__ 2.0. Specific Aims. Research has shown that people with IDD have poorer health than their non-disabled peers (73, 143). In the past decade, government initiatives such as "Closing the Gap: a National Blueprint to Improve the Health of Persons with Mental Retardation (143) and "Call to Action to Improve the Health and Wellness of Persons with Disabilities" (141) have helped to set the policies later described in Healthy People 2010. A recent review of work to date on translation of these policies into practice with people with IDD (82) indicates that health promotion programs have been effective in improving quality of life, especially in self-reported lifestyle behaviors. Areas that have not shown improvement are nutrition and physical activity (PA). Rimmer and Yakima (118) have estimated adults with IDD have more than 1.5 times the prevalence of obesity than in the general population. In individuals with IDD, the living arrangement (parent, group home, care giver, etc.) appears to be related with the prevalence of obesity with the least restrictive environments associated with the highest rates of obesity (82, 113). Krahn and Drum (82) and Rimmer et al (113) have concluded that successful health promotion strategies for individuals with IDD need to consider the impact of their living situation. The self advocacy movement, often referred to as self determination, also may have contributed to the increased prevalence of overweight and obesity in individuals with IDD. Wehmeyer (156) defined self determination as acting as the primal agent in one's life and making choices and decisions without undue pressure. Health promotion strategies for adults with intellectual or developmental disabilities should foster decision making and self determination (136). Individuals with IDD learn in school that they have the right to make major lifestyle choices. Agencies that serve these individuals typically empower them to make lifestyle choices. Most adults with IDD can choose where to live or work, control their daily schedule including how to spend their free time, what and how much to eat or drink, whether to participate in PA and what to purchase with their spending money (83). In regards to diet and PA, the choices often made by individuals with IDD (high calorie/fat foods, limited PA) are not different from those made by a majority of the general population. Results from our pilot study indicate that many persons with IDD have the desire and ability to lead a healthy lifestyle, including consuming a healthy diet and participating in PA. However, their living arrangement often makes choosing healthy alternatives difficult. In facilities with multiple residents, meal planning may be decided by the majority of residents and/or the care giver and meal preparation may be entirely the responsibility of the care giver. For expediency, care givers generally serve the same foods and portion sizes to all residents, regardless of differing energy needs. Individuals living with fewer residents or with a parent as the care giver, are frequently given free choice of diet including serving size, second servings, and snacks. Unfortunately the choices are generally not conducive to maintenance of a healthy weight as demonstrated by the high rate of obesity in this population. Likewise, living arrangements also create financial, transportation and logistic barriers to participation in PA. In the current proposal we will evaluate the efficacy of a system that offers individuals with IDD dietary choice within a constellation of options that can contribute to weight loss and weight maintenance and simplifies the prescription and logistics associated with participation in PA. We have recently completed a 6 month pilot investigation on weight loss in 73 individuals with IDD. We modified the Stop Light Diet (44) to include pre-packaged meals (PM) for 6 months for reduced energy and fat content, and encouraged consumption of low energy shakes and 35 fruits and vegetables (F/V) per week. This modified Stop Light Diet (SLDm) resulted in a 6.4% reduction in weight at 6 months different than the results from the successful Diabetes Prevention Program (80). We are currently following 66 and this is not dramatically of these participants for an additional 6 months (i.e.12 mo. total) and currently have 8.6% weight loss from baseline (Section 4.7.4). We believe these pilot results are encouraging and exceed the minimum of 3% weight loss suggested as clinically relevant in the recently published American College of Sports Medicine Position Stand "Appropriate physical activity intervention strategies for weight loss and prevention of weight regain for adults," (Donnelly primary author)(31). Therefore, we propose to conduct a randomized trial to evaluate behavioral strategies for weight loss and weight maintenance using both sides of the energy balance equation (i.e. energy intake and energy expenditure) in overweight and obese individuals with IDD. We will compare participants who use the SLDm with participants who use a reduced energy and fat diet with meal plans, patterned after the recently published "Position of the American Dietetic Association: weight management." (133). This diet is widely promoted as recommended care (RC) for weight reduction. Following a 6 month period of reduced energy intake (weight loss), both groups will be placed on a diet with sufficient energy to maintain weight (weight maintenance) for an additional 12 months for a total intervention of 18 months. During the weight maintenance period the SLDm group will continue to use SLDm including the use of PM and the RC group will continue to use meal plans. Both groups will participate in a PA program that has been shown to improve metabolic risk factors such as blood pressure (39, 41), triglycerides (39, 41), cardiovascular fitness (107, 115), and provided modest weight loss in gymnasium and laboratory settings for individuals with IDD. In the current proposal the PA program will be modified for home use and conducted for the entire 18 month trial. The use of PM is an emerging strategy for treatment of obesity in the general population and was effective for weight reduction and was well received by participants in our pilot study (Preliminary Studies). PM have consistently shown greater weight loss when compared with traditional meal plans in the general population, a finding that was supported by the results from our pilot in individuals with IDD (Section 4.7.4). We believe PM are well suited for incorporation in the SLD and for use in the supported living conditions currently found with many individuals with IDD. PM will provide portion control and will diminish the burden of planning and delivering the diet when compared with traditional meal plans. In addition, we believe incorporating PM with the SLD will facilitate significantly greater weight loss in individuals with IDD than that shown in the limited available literature using meal plans (+0.68kg to -3.4.kg) and will also improve the likelihood of weight maintenance (29, 158, 159). 2.1. Primary Aim 1. Weight Loss. We will compare weight loss at 6 months (0-6 months) between an experimental diet and a recommended care diet (RC) both with 500-700 kcal/d energy deficit. The experimental diet is the Stop Light Diet modified (SLDm) and includes PM, 35 F/V per week, and low energy shakes. We will compare this to the RC diet that uses traditional meal plans and includes 35 F/V per week. Both groups will participate in PA during the weight loss period. We expect the SLDm group will have significantly greater weight loss at 6 months versus the RC group. 2.2. Primary Aim 2. Weight Maintenance. We will compare changes in weight over 12 months (6-18 months) following weight loss between the SLDm group and the RC group at a level of energy intake designed for weight maintenance. Both groups will participate in PA during the 12 month period. We expect the SLDm group will have significantly less weight regain over the 12 month follow-up versus the RC group. 2.3. Secondary Aim- Risk factors. We will compare chronic disease risk factors between the SLDm and the RC group. We expect that the SLDm group will have significantly greater reductions during weight loss (0-6 months) for blood pressure, glucose, insulin, and LDL-cholesterol and higher values for HDL-cholesterol at 6 months versus the RC group and we expect likewise during the 12 month maintenance period (6-18 months). 2.4. Exploratory Aims. We will examine the impact of the SLDm and RC interventions on potential mediators of weight loss at 6 months, including energy balance variables (dietary intake, PA), process variables (self- monitoring, adherence) and psychosocial variables (care giver self-efficacy and daily stress related to dietary change). We expect individuals with IDD in the SLDm group will show greater improvements in dietary intake compared to the RC group. We expect individuals with IDD in the SLDm group will demonstrate better adherence to the intervention compared to the RC group. Finally, we expect care givers will report greater improvements in self-efficacy for weight management, and lower daily stress for dietary change compared to the RC group. Description and rationale for these potential mediators are found in Section 5.8.5 and analysis in Section 5.11.3.